Translational Research Training inCancer Etiology & Prevention

Given the severe shortfall of research scientists who are capable of conducting comprehensive studies
that can translate fundamental knowledge from the bench to the clinical and the community settings for the
improvement of cancer prevention and control, the purpose of this research training program is to provide
integrated training in an inter-disciplinary research and teaching setting at the University of Pittsburgh Medical
Center (UPMC) Hillman Cancer Center. Trainees will be trained in understanding the role of environmental
exposures and genetic and other physiological factors in the development and progression of cancer in
humans. The training program involves cross-disciplinary training courses in different tracks in the Clinical
Trial Research, the Translational Research, and the Population-Based Observational and Interventional
Research on cancer. Trainees will work with experienced mentors in a multiple disciplinary team conducting
researches from mechanistic experiments and observational studies in populations to randomized intervention
studies to test the efficacy of chemo- and immuno-preventive agents on cancer protection in humans. The
mentored research will provide direct research experience to trainees in study design, methodological
development, implementation of research protocol, data collection, analysis and interpretation, and manuscript
preparation and publication. Trainees also will learn how to translate discoveries from pre-clinical experimental
and/or observational studies into randomized interventional studies for cancer prevention. The unique training
of this program will train next generation of scientists who can lead the cutting-edge translational research on
cancer etiology and prevention.
This training program is a joint effort of 23 preceptors who are conducting active research projects all
with independent research funding in University of Pittsburgh. These faculties are from the following research
programs: Cancer Epidemiology and Prevention Program; Breast and Ovarian Cancer Program; Biobehavioral
Oncology Program; Cancer Immunology Program; Cancer Therapeutics Program; Head & Neck Cancer
Program; Lung Cancer Program; and Molecular and Cellular Cancer Biology Program at the UPMC Hillman
Cancer, a top-ranked Comprehensive Cancer Center with $94 million direct research funding in 2017. Trainees
will receive cutting-edge translational research training and experience.
We request continuing funding to support 3 postdoctorates and one predoctorate per year for 5 years.
Our recent data on applicant recruitment, retention and training experience demonstrate a relatively large pool
of candidates with high academic performance. In addition, we successfully enrolled one-third trainees from
the underrepresented racial and ethnical groups. The progress and success of the training program will
continue to track the career development and research activities of past trainees in the 10 years post-training.

Public health relevance
RELEVANCE. This training program will create a new generation of researchers superbly trained in multidisciplinary settings with a broad perspective and knowledge concerning basic, epidemiologic and clinical sciences. This new generation of scientists will be competent to undertake multiple disciplinary etiologic and preventive research that translates the discoveries in pre-clinical experimental and observational studies into randomized interventional studies for Eliminating the Suffering and Death due to Cancer, the ultimate goal set forth by NCI.